Resource Development Core

SUMMARY: MAYO RESOURCE DEVELOPMENT CORE (RDC)
As described in the RFA of the Polycystic Kidney Disease Core Centers (U54), “the overall goal of the RDC is
to establish and nurture a dynamic ‘incubator space’ that promotes innovation and ensures robust validation
of new resources” and “a RDC is expected to demonstrate innovative strategies and capabilities to develop
novel tools, models, and technologies”. Therefore, the objectives of the Mayo RDC are to provide this incubator
space for Mayo investigators to explore new approaches through the development of expertise from their
laboratories and the institution. The development and application of new technologies and methods is central
to groundbreaking discoveries that lead to a better understanding of disease pathogenesis and the
development of new therapies for PKD. Despite substantial progress in the identification of new disease-
causing genes, variants, and molecular etiologies, there are limited targeted therapeutics and a deficiency of
molecular biomarkers for ADPKD that can predict disease severity and progression as well as response to
therapy. In addition, there are limited human ADPKD model systems that are valuable for understanding
pathogenesis and testing new therapies. The extensive expertise and capabilities of Mayo Clinic Polycystic
Kidney Disease Research Core Center (MPRC) investigators in state-of-the-art technologies and
methodologies, and experience, knowhow and equipment of Mayo Clinic institutional cores illustrate potential
areas to explore in the Mayo Resource Development Core (RDC). Although we note that the specific areas to
be explored will be determined by the PKD-RRC Steering Committee. Areas of focus where we have specific
expertise and experience that could be developed in this Core are to: 1) Develop reagents to enable genome
editing in ADPKD, to target a range of ADPKD point and truncated mutations to facilitate specific and precise
therapeutic strategies based on each patient's unique genetic makeup; 2) Develop PKD models of human
stem cell-derived kidney organoids, to better model and test gene based therapies for the human disease;
3) Develop advanced imaging acquisitions and artificial intelligence (AI)-based image analysis
software to monitor the progression of PKD, to more precisely determine disease severity; and 4) Develop
capabilities for biomarker detection with cell free (cf)DNA and metabolomics approaches, to identify
novel biomarkers in ADPKD. These areas are highlighted not only because of Mayo expertise in these areas
but also the high potential impact if significant developments are made in any of these areas. The generation
and sharing of new cutting-edge reagents and techniques are central to the development of novel therapeutic
strategies and accurate monitoring of disease progression and response to treatments in ADPKD.